A Safe, Fast, and Cost-Effective System for Tissue Removal in Laparoscopic Hysterectomy and Other Minimally Invasive Surgery

Abstract
In the United States approximately 500,000 hysterectomies are performed per year, typically for uterine
enlargement due to fibroids. In 2014 the FDA provided guidance against uncontained laparoscopic power
morcellation, a method of rapidly removing a large uterus during minimally invasive surgery. The FDA determined
that power morcellators increased risk of cancer spread in women undergoing laparoscopic gynecologic surgery
for presumed benign fibroids. Preventing the spread of occult cancers during minimally invasive surgery is an
unaddressed need across many procedures, including: hysterectomy, myomectomy, colectomy, oophorectomy,
splenectomy, and nephrectomy. The FDA guidance left gynecologic surgeons without great tools for removing
large uteri minimally invasively. The primary technique developed in response to the guidance, called contained
manual morcellation, requires putting the uterus in a container and extracting it with a scalpel and graspers
through an incision in the abdomen or out the vagina. The technique is slow (often requires 10-20 scalpel blades
and takes 20-60 minutes), and ineffective at containing cancer cells (8-41% documented container breaches).
Another alternative, open surgery, is costly (~2.75 nights in the hospital) and has high associated morbidity /
mortality (1:5000 mortality, 1:20 serious complications).
Claria Medical is developing the Claria System which enables the safe, rapid and cost-effective removal of
large uteri minimally invasively. The improved surgical speed and safety the Claria System provides enables
surgeries to be performed in a same-day outpatient format avoiding open surgery, complications, and long
hospital stays. The key milestone of this Phase IIb proposal is to submit Claria System to the FDA for De Novo
clearance. Aim 1 focuses on design optimization, execution of final design verification and validation protocols
to address new FDA requirements, and submission to the FDA. Aim 2 is an ex-vivo evaluation that performs a
controlled comparison of the Claria System to the current gold standard ExCITE technique, specifically
evaluating speed of extraction. Aim 3 addresses some final manufacturing and process validation testing to
enable high volume manufacturing of the devices. As for future work, subsequent to FDA De Novo clearance,
Claria will perform an additional post-market clinical evaluation, a commercial launch, and clinical studies in
additional indications for benign and malignant tissue removal.

Public health relevance
Narrative Minimally invasive hysterectomies which require benign tissue reduction and removal are estimated at over 160,000 per year in the United States. Current methods have several pain points: High complication rates, high cost, and slow speed. We propose a safe, rapid, easy to use, and cost-effective tissue removal system that can aid in hysterectomy and other minimally invasive surgeries which require tissue reduction.